Genome-wide screening for host lncRNAs regulating host defense against Mycobacterial infection in macrophages

Project Summary
Tuberculosis (TB), caused by the intracellular bacterial pathogen Mycobacterium
tuberculosis (M.tb), remains one of the most deadly infectious diseases in the world.
According to the WHO annual report, one third of the population has been infected by
M.tb across the world, leading to 10 million active TB cases and 1.4 million deaths in 2019.
About 5-10% of infected people develop active TB disease during their lifetime. The
mechanism of M.tb-host interactions remains to be defined. Host long noncoding RNAs
(lncRNAs) are noncoding RNAs with greater than 200 nucleotides. Our preliminary data
and previous publications demonstrated the engagement of host lncRNAs in host defense
against mycobacterial infections in macrophages. However, there are limited studies
addressing the functions of host lncRNAs in the context of M.tb infection. The long-term
goal of this proposed study is to identify host lncRNAs that are beneficial to host defense
against M.tb infection in macrophages, and further understand the mechanism how host
lncRNAs serve as cis- or trans-regulatory elements in mediating the host immunity in
macrophages in response to M.tb infection. In the current proposal, we hypothesize that
lncRNAs are essential components of antimycobacterial response within M.tb-infected
macrophages. To test the hypothesis, we propose a genome-wide screening for host
lncRNAs that regulate host defense against mycobacterial infection in human
macrophages using a CRISPR-Cas9 transcription activation system that targets over
10,000 host lncRNAs. Aim 1 will screen host intergenic lncRNAs that improve the survival
of THP-1 cells during M.tb infection. Aim 2 will validate candidate host lncRNAs in
genetically engineered THP-1 cells during the course of M.tb infection. Nucleic acid-
based therapy is becoming an emerging new class of therapeutics for treating unmet
medical conditions. Our study will shed light on the development of nucleic acid as a novel
host-directed therapy for the treatment of TB, especially drug-resistant TB.

Public health relevance
Project Narrative An increasing body of studies demonstrated that host long noncoding RNAs play critical roles in host defense against microbial infections. However, we know little about their function in host response to Mycobacterial tuberculosis infection that causes tuberculosis, one of the most deadly infectious diseases across the world. In this proposal, we will perform a genome-scale screening to identify antimycobacterial long noncoding RNAs and further understand associated regulatory mechanism in macrophages during mycobacterial infections.